Structure, Turnover and Safeguard of Mitochondria

Summary
Mitochondria are essential organelles that control the life and death of cells. Mitochondria
are highly dynamic: They grow, divide, and fuse, and when they eventually become damaged,
undergo degradation Mitochondrial division is mediated by a dynamin-related GTPase, DRP1,
while fusion is mediated by two dynamin-related GTPases, OPA1 and mitofusin. These
GTPases are mutated in human diseases, including neurodevelopmental disorder, Charcot-
Marie-Tooth neuropathy, and optic atrophy. Altered activities of these proteins have also been
linked to metabolic syndrome, cardiovascular disease, and age-related neurodegeneration. My
laboratory’s goal is to decipher the molecular mechanisms that control mitochondrial structure
and translate the fundamental biology to disease interventions. In the past two decades, we
have identified and characterized the three essential GTPases in the core reactions of
membrane fusion and division. The roles of mitochondrial dynamics are ever-expanding, and
now include size control of mitochondria, their distribution and turnover, and differentiation of
neurons, cardiomyocytes, stem cells, and immune cells. Most recently, it became evident that
the mechanisms of mitochondrial division and fusion are much more complex than initially
imagined, involving inter-organelle interactions and a feedback response that monitors and
tunes their balance. The emerging new biology is transforming the field of mitochondrial
structure and dynamics. In the next 5 years, we will address the important questions raised by
this intellectual evolution.
First, to our surprise, we found that DRP1 shapes the endoplasmic reticulum (ER) into
tubules that form contract sites with mitochondria. DRP1-produced ER-mitochondria contact
sites strongly promote mitochondrial division. We will investigate how DRP1 creates ER-
mitochondria contact sites that specifically function in mitochondrial division, associates
with the ER, and deforms the ER membrane. Second, we discovered a physiological pathway
of mitochondrial turnover via DRP1-controlled, Parkin/PINK1-independent mitophagy in mice.
This pathway’s most upstream event is to recognize and mark damaged mitochondria by
ubiquitination of mitochondrial proteins. Our initial experiments suggested that ubiquitination
occurs in two phases – reversible initiation and committed amplification. We will determine
what ubiquitinates mitochondria in each phase, and how the ubiquitin ligase complexes
recognize and label damaged mitochondria in vivo. Third, we found the first example of a
stress response (MitoSafe) that senses and adjusts the mitochondrial structure by controlling
the balance between fusion and division. We will explore the molecular basis of MitoSafe
and its physiological roles in mice. The MIRA grant will enable us to discover the new logics
of mitochondrial structure and its physiological role and regulation in vivo.

Public health relevance
Project Narrative Defects in mitochondria structure and function have been linked to human health problems including metabolic syndrome, cardiovascular diseases, and neurodegeneration. This proposal aims to determine fundamental mechanisms that control structure, turnover, and safeguarding of mitochondria. The successful completion of this work will provide major insights into the pathogenesis and treatment of human disease.